OspC and its role in defining host range and dissemination properties

Project summary: Lyme disease is the most common tick-borne disease in the northern
hemisphere. The incidence of Lyme disease is steadily increasing as the Ixodes tick population
expands. This proposal will identify the critical functional determinants of outer surface protein C
(OspC), an essential virulence factor. In addition, we will determine how sequence variation in
OspC influences infectivity and dissemination properties. Cutting edge genetic approaches will
be employed to dissect the role that OspC plays in the pathobiology of the Lyme disease
spirochetes. The outcome of these analyses will also advance ongoing efforts to develop
vaccines and diagnostic antigens for use in humans.

Public health relevance
Project narrative: Lyme disease remains an important public health issue. This work will identify the functional determinants of outer surface protein C, an essential virulence factor required for the ability of the Lyme disease spirochete to transmit from ticks and establish infection in mammals. The outcome of these analyses will enhance our understanding of the molecular mechanisms of pathogenesis for these important pathogens and provide information that can be exploited in the develop of improved preventive and therapeutic strategies for Lyme disease.